HERCULES: Exposome Research Center

HERCULES: ENVIRONMENTAL HEALTH DATA SCIENCE CORE – SUMMARY
Partnering with HERCULES Cores that define and apply (Community Engagement Core, CEC), innovate (Pilot
Project Program, PPP), operationalize (Integrated Health Sciences Facility Core (IHSFC), and coordinate and
evaluate (Administrative Core), the Environmental Health Data Sciences Core (EHDSC) functions to enable
and interpret translational research on the exposome. Specifically, the EHDSC will: 1) Develop and support
data pipelines linking the wide range of HERCULES Members’ datasets to projects large and small (Aim 1); 2)
Advance expanded and customized data management and analysis plans, implement novel analytic
approaches, and expand the HERCULES data and analytic infrastructure (Aim 2); and 3) Provide in-depth
introductions and training sessions for HERCULES Members and partners focusing on data science principles,
statistical and machine learning design and analysis, and analytic modeling tools of computational systems
biology (Aim 3). All three functions are essential to translate exposome-related data of different measurement
types taken from different places at different times into informative, interpretable, and communicable results for
community members, stakeholders, researchers, and policy makers. Building on a connected collaborative
network between our experienced data science professionals and HERCULES Members and community
partners, the EHDSC will 1) provide the Administrative Core with insight into existing and emerging trends in
data management and analysis from inside and outside the HERCULES community in order to assure training
of all Members and support for new and early career investigators; 2) collaborate directly with the CEC in
working with HERCULES community partners to identify relevant existing data sources, partnerships with
HERCULES Members, and/or support citizen science efforts to provide data collection, data management, and
data communication plans; 3) partner with the IHFSC to link health outcomes and exposure measurements in
innovative ways quantifying, operationalizing, and interpreting exposome data within translational
environmental health research; 4) accelerate the innovative research of the Pilot Program by providing
needed support across a range of data science needs. Taken together, the EHDSC provides clear
connections to all elements of HERCULES and complements the Administrative Core, the CEC, the Pilot
Program, and the IHSFC through close collaboration in our overall mission of learning how the exposome
affects health and community well-being and using that knowledge to improve human health.